P30 Core Grant for Vision Research

Project Summary: Overall
The Massachusetts Eye and Ear (MEE) is an internationally-recognized leading institution for
academic ophthalmology and vision research. MEE is the primary institution for the Department of
Ophthalmology at Harvard Medical School, one of the largest academic departments of
Ophthalmology world-wide. The overall purpose of this P30 Center Core Grant for Vision Research is
to enhance the research capabilities at MEE by providing resources that would not otherwise be
available to investigators who are PIs of NEl-funded R01s. The Core resources have increased
research productivity, supported collaborative research, supported young investigators and have
contributed to successful faculty recruitment. Through collaboration with MEE vision scientists new
faculty have been attracted to vision research. This P30 competing renewal requests funds to support
four resource cores: Genomics, (Eric Pierce director), will provide access to state-of-the-art genomic
resources; BioBank, (Janey Wiggs, director) will support the collection of patient-related samples and
provide support for linking patient material with genomic and clinical data; Bioinformatics and
statistics (Lucia Sobrin, director) will provide resources and support for a variety of bioinformatics and
statistical analyses including analysis of next generation sequence data, genetic associations, power
calculations and analysis of gene expression data; and Functional Genomics (Kinga Bujakowska,
director) will support a zebrafish facility for functional analyses of disease-related genes and
mutations. These resources form the basis of an integrated research plan that enhances the research
capabilities at MEE and in particular supports the clinical translation of basic science discoveries.
Four general research themes are supported by this research plan: genetics and genomics of ocular
disease, identification of risk factors for common complex ocular disease, defining the molecular
basis of ocular infection and antibiotic-resistant infections, and the cell and molecular
biology of neuro-degenerative conditions affecting the eye. The overall goal of the core facilities is to
enhance the productivity of individual research programs, create opportunities for new research
endeavors, and promote collaborative efforts in identifying the molecular, cellular and genetic bases
of biological and disease processes
OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page

Public health relevance
Project Narrative - Overall This P30 Center Core Grant for Vision Research provides critically important resources that support the overall research program at the Massachusetts Eye and Ear Infirmary, and in particular supports the translation of new knowledge into clinical information that positively impacts the diagnosis and care of patients affected by blinding visual disorders.